Outreach, Training, and Education Core (OTEC)

The Outreach, Training, and Education Core aims to advance awareness, knowledge, and skills
in temporomandibular disorders (TMDs) through comprehensive, stakeholder-driven programs
that promote interdisciplinary collaboration, evidence-based education, and community
engagement. By partnering with organizations like the United States Association for the Study of
Pain, the American Academy of Orofacial Pain, and the Orthopaedic Research Society, the
Core will integrate dental, medical, and orthopedic perspectives into TMD research and
education, while leveraging networks such as the NIH PURPOSE initiative and the National
Dental Practice-Based Research Network to identify and address knowledge gaps. These
efforts will be further supported by collaboration with patient advocacy groups, including the
TMJ Association, to ensure that People with Lived Experience (PWLE) contribute meaningfully
to the research process, from proposal review to clinical practice implementation. Biannual open
forums will foster interdisciplinary dialogue, enhance stakeholder input, and facilitate
dissemination of findings. The Core will also develop innovative training programs, including
TMD-focused modules integrated into existing NIH-funded pathways like T32 and T90/R90, to
strengthen the pipeline of skilled clinicians and researchers. Unified, standardized curricula for
medical, dental, and allied health professions will incorporate interprofessional training sessions,
fostering collaboration and equipping the next generation to address the complexities of TMD
care. By uniting diverse stakeholders and addressing critical gaps in education and outreach,
this initiative will enhance practitioner knowledge, empower patients, and drive advancements in
TMD care, ultimately improving outcomes through a multidisciplinary and evidence-based
approach.